INTRAVENOUS GAMMA GLOBULIN TREATMENT OF KAWASAKI'S SYNDROME

The purpose of this study is to assess the efficacy of intravenous gammaglobulin (IVGG) in preventing coronary artery lesions and to evaluate possible etiologic factors.